Neural Stem Cell Extracellular Vesicle Treatment for Traumatic Brain Injury

Project Summary/Abstract
Traumatic brain injury (TBI) is a universal health concern and is known as a “silent epidemic”. Each year
in America, 2.53 million patients visit the emergency department after suffering a TBI of which 56,800 die and
over 288,000 require hospitalization, rehabilitation programs, and long-term supportive care. Although the
primary TBI event is typically acute, subsequent secondary injury responses (neuroinflammation) and chronic
tissue loss often result in functional deficits that last a lifetime. Presently, there are no neuroprotective or
regenerative Food and Drug Administration approved TBI treatments. Aruna Bio has recently developed a novel
neuroprotective and regenerative neural stem cell extracellular vesicle (NSC EV) product called AB126™ that
may be used to treat TBI. AB126™ has demonstrated multimodal therapeutic efficacy in divergent species (aged
mouse, rat, pig) and neural injury models (TBI, stroke). In TBI rodent models, AB126™ reduced lesion sizes,
enhanced endogenous neurogenesis and angiogenesis, and rapidly attenuated motor function impairments.
Large animal testing has been repeatedly identified by academic, industry, and government agencies as a key
de-risking step in TBI therapeutic development. To this end, this proposal outlines FDA enabling studies in a pig
controlled cortical impact TBI model using clinically relevant assessment tools to evaluate the efficacy and safety
of AB126™ as a treatment for TBI. The successful completion of this study will provide key information pertaining
to AB126™ dosage, therapeutic effects on TBI pathophysiology (edema, hemorrhage) and functional outcomes,
toxicity, and potential adverse side effects that will serve as the basis for an IND submission and future clinical
trials.

Public health relevance
Project Narrative (3 sentences) Traumatic brain injury (TBI) is a “silent epidemic” as 2.53 million patients visit the emergency department every year of which 56,800 patients die. Aruna Bio has recently developed a multimodal neuroprotective and regenerative neural stem cell extracellular vesicle (NSC EV) product, AB126™, to treat TBI that has demonstrated significant efficacy for TBI indications. The successful completion of the proposed study will provide key information pertaining to AB126™ dosage, therapeutic effects on TBI pathophysiology (edema, hemorrhage) and functional outcomes, toxicity, and potential adverse side effects that will serve as the basis for an IND submission and future clinical trials.